Maternal effect on offspring immunity against hepatitis B virus

Hepatitis B virus (HBV) can cause severe liver diseases including cirrhosis and hepatocellular carcinoma
(HCC). There are approximately 250 million people in the world that are chronically infected by this virus,
resulting in 0.5-1 million deaths every year. Most chronic HBV carriers acquired the virus early in life from their
infected mothers. In contrast to the mother-to-child transmission (i.e., vertical transmission), patients who
acquired HBV from unrelated inviduals (i.e., horizontal transmission) will usually develop self-limited acute
infection. Why vertical transmission leads to chronic infection whereas horizontal transmission leads to self-
limited acute infection was unclear. Our recent studies indicated that HBV in the mothers could suppress anti-
HBV immunity in her children to promote HBV persistence in the latter. HBV has a very narrow host range, which
has greatly hampered its research. We have recently developed a mouse model to study the maternal effect on
HBV persistence in her offspring. By crossing female hemizygous HBV transgenic mice to male naïve mice, we
obtained non-transgenic mouse pups. When these non-transgenic mouse pups were injected with the HBV
genomic DNA by hydrodynamic injection, the HBV replication persisted in the mouse liver for up to 28 weeks.
This is in contrast to control mice born to non-transgenic mothers, which cleared HBV after 3-4 weeks of HBV
DNA injection. Our further studies indicated that maternal HBV could condition hepatic macrophages of the
offspring, which would undergo M2 polarization to suppress HBV-specific CD8+ T cells after the introduction of
HBV into the mouse liver. The goal of this application is to continue our previous studies to further understand
the maternal effect on offspring immunity against HBV. Specifically, we will determine how HBV in the mother
impacts HBV-specific CD8+ T cells and hepatic macrophages of the offspring. We will also determine whether
and how maternal HBV affects the myeloid-derived suppressor cells (MDSCs) of the offspring and the possible
roles of MDSCs in the suppression of anti-HBV immunity in the offspring. Finally, we will investigate the possible
effect of gut microbiota and their metabolites, specifically butyric acid, on HBV replication and anti-HBV immunity
of the offspring. The proposed studies will provide important information for us to understand the mechanism of
HBV persistence after its mother-to-child transmission and facilitate the development of novel therapeutic options
for chronic HBV patients.

Public health relevance
PROJECT NARRATIVE Chronic hepatitis B virus (HBV) infection can lead to severe liver diseases and is responsible for 0.5-1 million deaths every year in the world. Most chronic HBV carriers acquired the virus from their mothers. The goal of our proposed research is to understand how HBV establishes persistent infection after its mother-to-child transmission, with the eventual goal of developing better treatments for HBV patients.